Macrophages in Cardiovascular Health

Inflammation is seen as an unrealized therapeutic opportunity in cardiovascular disease (CVD),
and the field is poised to recapitulate immunomodulatory drug breakthroughs that recently
happened for cancer patients. In this application, I propose expanding our understanding of
innate immunity in CVD, a necessary step to identify therapeutic targets that do not sacrifice
host defense. I will ask the overarching question how macrophages influence cardiovascular
health and disease. I will focus on these innate immune cells because they are among the most
numerous in the healthy and diseased arterial wall and the myocardium, and because these
cells are not only influential for their surrounding tissue environment but also undergo vast
quantitative and phenotypical changes when exposed to cardiovascular risk factors. For
example, bone marrow-derived macrophages can destabilize the arterial wall, triggering
ischemic events. Physical activity protects against these events, an insight that may hold
lessons for drug development. Now is an opportune time to unleash single cell imaging and
omics to identify harmful macrophage subsets and their functions, pursuing regulatory pathways
that can serve as immunomodulatory targets. In addition to their actions in destination tissues,
the application focusses on mechanisms that lead to overproduction of monocytes in the bone
marrow of patients with increased cardiovascular risk, because monocytosis associates with
patients' cardiovascular mortality. My mission is strengthened by a strong translational
perspective: the discovery pipeline is guided by clinical data and observations. I will tackle three
major goals: 1. to understand the role of macrophages in preserving cardiovascular health, 2. to
illuminate their contributions to CVD and 3. to use this insight to define new therapeutic targets
for female and male CVD patients. My ultimate goal for this program is a macrophage drug
target for CVD, meeting the high level of ambition stipulated by the program's RFA.

Public health relevance
In this application, I will test the overarching hypothesis that macrophages are suitable targets for immunomodulatory therapy in inflammatory cardiovascular disease. Towards this goal, I will examine pathways that lead to pathologic macrophage actions, studying their sources, subsets and phenotype transitions in the bone marrow, blood, arterial wall and the heart.